Washington National Primate Research Center

ABSTRACT
The number of NIH-funded research projects using imaging technology in large animals has been steadily
increasing at the University of Washington. One challenge has been the lack of access to 3D x-ray computed
tomography. While 2D x-ray radiographs can provide valuable information, there are many use cases in which
radiographs provide insufficient information to support funded research studies maximally. The equipment
proposed is a Philips Incisive Prox-ray computed tomography (CT) scanner for use in the Animal Research and
Care Facility (ARCF) at the University of Washington, under the leadership of the Washington National Primate
Research Center (WaNPRC). An important role for the CT scanner is to assist in the placement and monitoring
of the position of subdural EEG and other electrodes in the brains of primates as well as the surgical planning
for cranial implants, leading to better research outcomes and improved animal welfare. Another need is to use
CT imaging to image infection in the lungs to monitor changes and visualize pulmonary infiltrates in long-term
studies of maternal-fetal immunology and vaccine/therapeutic studies. Finally, CT imaging capability at the
University of Washington will support Veterinary Services by providing more accurate diagnoses and prognoses
to guide clinical treatment for nonhuman primates and other large animal models in research projects. The
proposed equipment will not only help currently funded research projects but will also accelerate and facilitate
novel, future imaging research projects targeted for NIH support.

Public health relevance
PROJECT NARRATIVE This supplement request is for funds to purchase a CT scanner for the Washington National Primate Research Center. The proposed CT scanner will serve clinical and research purposes across multiple areas of biomedical research including neuroscience, infectious disease and gene therapy and regenerative medicine. Creating 3D radiographic images will be used to guide veterinary care and research procedures enhancing animal welfare and increasing successful research outcomes.